Towards Human-Centered Rehabilitation: A Focus on Embodiment and User Perception of Upper Limb Prostheses

PROJECT SUMMARY
Loss of an upper limb can greatly impact the ability to perform daily tasks, work, and participate in social contexts,
so a major goal of rehabilitation for individuals with upper limb loss is to facilitate their full engagement in all
aspects of life. While a common research objective is to support these individuals through the development of
more advanced prosthetic limbs, the experience of disability is also shaped by physical, biological, and social
factors beyond the prosthesis itself. A human-centered approach to rehabilitation that addresses these
interconnected factors could be more effective for enabling functional success in this population. An emerging
concept that may be useful in this application is embodiment, or the perception that the prosthesis is part of the
user’s body, but the relative importance of embodiment compared to other factors that influence prosthesis use
is not well-understood. In particular, it is unknown if prosthesis embodiment is actually a desired outcome among
individuals with upper limb loss. It is also unclear whether all individuals are equally capable of embodying their
prosthesis, or whether they differ in their ability to acquire the requisite skills that would facilitate embodiment.
There are numerous sources of error during prosthesis use, which come from both the user and the prosthesis,
that could inhibit the experience of embodiment if individuals are unable to adequately compensate. Thus,
variance in the experience of embodiment between individuals may be related to how they detect and adapt to
with these error sources. The goal of this proposal is to better understand variation in the desire and ability of
individuals with upper limb loss to experience prosthesis embodiment. In Aim 1, we will explore how individuals
with upper limb loss perceive the necessity of prosthesis embodiment. We will conduct semi-structured interviews
related to their experience or lack of experience with embodiment, using questions developed in consultation
with individuals with upper limb loss. In Aim 2, we will examine the role of user-related and prosthesis-related
error in determining movement adaptation and embodiment in upper limb prosthesis users. This will be
accomplished using virtual cursor control tasks to separate the error sources and quantify embodiment, along
with correlations to assess whether individual skill in error compensation is associated with stronger embodiment.
Successful completion of this proposal will provide insight on the conditions under which upper limb prosthesis
embodiment arises and the extent to which embodiment is necessary for optimal engagement in different life
activities. This information can direct future assessments of prosthesis use to focus on the most impactful
contributors to functional success. Ultimately, these assessments could support the development of prosthesis
design and training protocols tailored to individual needs and preferences.

Public health relevance
PROJECT NARRATIVE The absence of an arm or hand can significantly limit an individual’s capacity to engage in daily activities, work, and social interactions, but the factors contributing to successful use of an upper limb prosthesis are not well understood. This project will investigate the relationship between embodiment (perceiving a prosthesis as part of the body) and other aspects of user performance with a prosthesis, as well as prosthesis users' perspectives on the importance of embodiment. These findings may lead to the development of improved prosthetic limbs, enabling individuals to participate more effectively in their desired life activities.